Admin Core

Administrative Core Summary/Abstract This core provides the administrative leadership, management and oversight of the Program Project. The overall goal of this core is to ensure responsible and responsive management of the program as a whole, promote collaboration between the subprojects, and to aid in transparent dissemination of the program output (the Phenix software) to the research community. The Project Director will provide budget oversight for the whole project, set the scientific goals for the whole program in collaboration with the project PIs, ensure program milestones are met in a timely manner, assess the progress in the individual projects, make significant changes in program composition if necessary, and report progress to the NIH program manager. The Project Director will promote, monitor and evaluate collaboration between the subprojects. Finally, this core will continue to be responsible for providing easy to use web services for downloading the Phenix software.